Interaction between Genome and Heavy Metals in Nonalcoholic Fatty Liver Disease

ABSTRACT
The ultimate goal of this project is to discover and validate the gene Х heavy metal (GXM) interactions in
human livers and to understand their role in nonalcoholic fatty liver disease (NAFLD). NAFLD is the most
common chronic liver disease affecting over 30% of the U.S population, resulting in a heavy social burden.
NAFLD is characterized by a spectrum of histological changes with multiple cells involved. Currently, no
approved drug treatment is available for NAFLD. Therefore, it is an urgent need to identify both genetic and
environmental risk factors to facilitate the development of new diagnostic, preventive, and therapeutic
strategies. NAFLD is a typical complex disease involving gene-environment (GXE) interactions. Over the past
decade, while GWAS for NAFLD have identified numerous genetic risk alleles, a growing body of research has
demonstrated that exposure to heavy metals (Pb, Cd, Hg, As, etc.) are associated with increased NAFLD risk.
However, there is no compelling study thus far to assess the correlation between various naturally
accumulated metals in human livers and the NAFLD histology, especially in clinically defined patient cohorts.
More importantly, there lacks critical knowledge about how naturally and chronically accumulated metals
interact with the liver genome and together confer risks for NAFLD. Our preliminary studies in human liver
tissues have successfully demonstrated that multiple metals are indeed correlated with NAFLD. By leveraging
our previously collected multi-omics data, we have preliminarily identified numerous metal-response genes
(MR-genes), expression quantitative traits loci (eQTLs), and allele-specific expression loci (ASEs), which are
further enriched to NAFLD and its related pathways. We aim in this study to further expand our study to a
large-scale, highly detailed, and integrated analysis to thoroughly understand the role of GXM interactions in
NAFLD in humans. To this end, our team has been collaborating to establish collections for human liver tissue,
cells and NAFLD patient cohorts. We have also developed various technical platforms e.g. bulk/single cell (Sc)
RNAseq and ATAC-seq, as well as multiple bioinformatics and statistical tools for GXE data analyses. With
these preparations, we specifically aim: 1) To profile heavy metals in frozen human liver tissues (n=560),
identify MR-genes, eQTLs/ASEs, and test their associations with NAFLD; 2) To treat the primary liver cell
populations with various metals and to elucidate how the genome of different liver cells respond to metals with
Sc-RNAseq and ATAC-seq, and 3) To validate the association between GXM interactions and NAFLD
histology severity in a large clinically defined NAFLD patient cohort (n=1313). Our study will for the first time
evaluate the role and mechanism of GXM interactions in NAFLD and will provide the scientific community
important data to open new avenues to NAFLD research, drug discovery, and beyond.

Public health relevance
PROJECR NARRITIVE Our project represents the first, large-scale, and most comprehensive effort to understand the gene-heavy metal interaction in human livers and its impact on nonalcoholic fatty liver disease (NAFLD). Our study has potential to identify high-risk metals and their key response genes, thus promoting the development of new strategies for NAFLD diagnosis, prevention, and treatment. Our study will also generate important data to be shared with the scientific community to advance research for NAFLD and other related diseases.